UROLOGIC ABNORMALITIES FOUND BY ANTENATAL AND PERINATAL ULTRASOUND

The purpose of this protocol is to assess the accuracy of antenatal ultrasound, as well as the natural history of neonatal obstructive uropathy. All fetuses detected by antenatal ultrasound to have kidney or bladder abnormalities will be prospectively studied. A record of outcome at birth will be kept, and if postnatal ultrasound is abnormal, we shall follow until a definite medical diagnosis is reached.